Longitudinal Investigation of the Neurobiological Underpinnings of Risk Behavior in ADHD throughout the Adolescent Transition: The Key Role of Cognitive Control and Motivation Network Development

PROJECT SUMMARY/ABSTRACT
Attention-deficit/hyperactivity disorder (ADHD) is the most commonly diagnosed developmental disorder of
childhood, affecting ~9% of children nationwide. Although ADHD dramatically increases the risk for poor
academic achievement, substance abuse, and criminal behavior, particularly in adolescence, too little is known
regarding how neurobiological developmental trajectories underlie these behavioral and clinical outcomes. This
remains the case in spite of the importance of such work for earlier identification of risk factors, more targeted
treatment models, and, in turn, education, juvenile justice, and healthcare savings for individuals, families, and
society. The goal of the parent grant, therefore, is to characterize longitudinal neural, behavioral, and clinical
trajectories of youth with ADHD from late childhood to mid-adolescence. Brain systems underlying cognitive
control and motivation in particular have been identified as centrally important both to the neural etiology of
ADHD and to the general increase in risk-taking behavior and poor decision-making observed in typically
developing (TD) adolescents. An important aspect of these models is how brain regions underlying these
processes form coherent networks, as well as how these networks interact and influence each other to produce
behavior. Here we bring together these two disparate literatures to gain understanding of the transition to
adolescence in youth with ADHD. Thus, the parent grant focuses on the maturational course of the cognitive
control and motivation systems, individually and in interaction, in youth with and without ADHD in a multi-session
longitudinal design. The specific aims of the parent grant include: 1) Characterize behavioral trajectories of
cognitive control, motivation, and their interaction in ADHD and TD youth from childhood into adolescence; 2)
Characterize the development of structural and functional brain network organization during the same time
period, focusing on brain networks underlying cognitive control and motivation; and 3) Identify neural, behavioral,
and clinical features of pre-adolescent ADHD that predict clinical outcomes and risk-taking behavior during
adolescence. To address these aims, innovative network analytic tools based on graph theory and structural
equation modeling will be applied to structural and functional connectivity estimates of MRI data during diffusion-
weighted imaging (structural) and during rest, cognitive control, motivation, and risk-taking tasks (functional).
Additionally behavioral performance on the cognitive control, motivation and risk-taking tasks, ADHD
symptomatology, and risk-taking attitudes and behavior will be assessed. The aim of this supplement is to
provide funds such that the acquisition of all planned MRI scanning can take place, given unanticipated costs in
collecting neuroimaging data as a result of: 1) increases in hourly rate; and 2) the need to schedule longer MRI
scan sessions in response to requirements of the imaging center. With this supplement, data collection can be
completed as proposed. Findings from this research will provide groundwork that can lead to early identification
and, ultimately, prevention of ADHD trajectories that are more likely to lead to adverse outcomes in adolescence.

Public health relevance
PROJECT NARRATIVE ADHD is a common and debilitating disorder that contributes to increased chance of deleterious risky behaviors that emerge or exacerbate in adolescence, leading to long-term negative outcomes such as addiction or incarceration. This supplement requests funds to complete MRI data collection for the parent grant, which consists of a comprehensive, longitudinal, multilevel (neural, behavioral, clinical) and multimodal (functional MRI, diffusion MRI) study in youth with ADHD across the transition to adolescence. By incorporating innovative brain network analytic tools and sophisticated longitudinal modeling techniques, this research will characterize developmental trajectories and identify childhood features that contribute to increased risk for negative outcomes in adolescence, leading to biomarker development for earlier detection of risk and more targeted treatment models for ADHD.